Regulation and maintenance of thiyl radicals in enzyme catalysis and protein degradation

Project Summary
Thiyl radicals lie at a perilous nexus between essential biological function as cofactors in enzyme
catalysis and toxic products of oxidative stress. As a cofactor, cysteine thiyl radicals facilitate a wide
range of C‐X (X= H, C, N, O, S, P) bond cleavage and formation reactions with high fidelity, requiring
selective thiyl radical generation, active site chemistry, and reduction. Their reactivity, particularly
within an active site with many weak C‐H bonds and oxidizable amino acid sidechains presents several
alternative fates, clearly manifest in thiyl radicals generated as the product of oxidative stress “off‐
pathway,” where they can form new S−S and S−C bonds, or catalyze other chemical modiﬁcations that
are deleterious to biological function. Understanding the structure/function relationship that dictates
thiyl radical fate holds promise in developing better therapeutics and antibiotics that target thiyl radical
enzymes, informing biomimetic or biocatalytic synthetic biology, and mitigating their role in oxidative
stress.
Understanding the mechanistic and contextual aspects of how thiyl radicals are generated and what
dictates their fate in proteins are essential to addressing their impact on human health. Our research
group is seeking to define how thiyl radicals that enable catalysis are selectively generated and
maintained, how this might inform therapeutic developments, and what determines the fates of
orphaned thiyl radicals. To these ends, we are employing genetic, chemical, and spectroscopic tools to
understand thiyl radical chemistry within proteins, from generation to termination, with kinetic and
thermodynamic resolution. As our proof‐of‐concept, we are applying these tools to the development
of mechanism‐based inhibitors for prominent thiyl radical enzymes in the gut, targeting Clostridioides
difficile, with precision. More broadly, however, by advancing our understanding of thiyl radical
chemistry in diverse protein milieu the resulting discoveries will provide new opportunities to
improve or target thiyl radical catalysis and rationalize oxidative stress pathways. Through
developments in each area, we will form the foundation of a holistic understanding of thiyl radical
chemistry in biology that we anticipate will have wide ranging implications, both in basic and applied
life and physical sciences.

Public health relevance
Project Narrative The proposed research will investigate biomolecular aspects of thiyl radical formation, chemistry, and reduction relevant to the fidelity of thiyl radical enzymes and their non‐specific reactivity. These studies will employ a variety of techniques and investigate thiyl radicals in a number of distinct contexts, broadening the impact of the findings. Ultimately, outcomes of the proposed work will inform rational therapeutic design, open the door for thiyl radical biocatalysis engineering, and strategic approaches to intercept reactive sulfur species involved in oxidative stress.